New protein-engineered tools and technologies for identifying, deorphanizing, and targeting shed proteins in cancer

Project Summary
Extracellular proteolysis is a hallmark of cancer and has major functional consequences for remodeling cell
surface proteins including receptor activation and shedding of functional extracellular domains. In our first RO1
grant, we successfully developed mass spectrometry-based proteomics technologies using subtilgase
conjugation to identify more than 2000 neo-proteolytic events on the cell surface; more than 90% of these were
new to the literature. We developed recombinant antibody selection strategies that can generate antibody tools
that selectively bind these neo-epitopes, or block them, and killed cancer cells. In this R01 renewal, we propose
to extend the technology from interrogating membrane bound events to shed events that exert autocrine effects
on cancer cells. We recently identified >200 shed candidates affected by oncogene transformation using
chemical proximity labeling techniques, and here we plan to expand identification and de-orphanization of the
binding functions for shed proteins. First, we will develop technologies to profile cell surface proteolysis and
secretome in cancer cells and human plasma (SA1). While it is well-understood that cancer genes aberrantly
regulate proteases, the substrates and molecular consequences of proteolytic events are poorly characterized.
We propose to characterize extracellular cleavage events that generate neo-N-termini on the cancer cell lines
using a mass spectrometry approach, and ultimately developing a publicly available extracellular proteomic atlas.
We will identify shed fragments in conditioned media from cancer cells and search for them in plasma of cancer
patients as potential biomarkers. Next, we will develop and utilize Multi-map proximity labeling techniques to
identify partners that shed proteins bind and interact with on the cell membrane (SA2). Initially, we will identify
autocrine partner proteins for two shed proteins vasorin and PTK7 we discovered previously as a first step in de-
orphanizing potential functions. Applying our new multi-range proximity labeling proteomics technology (Multi-
map) that can identify cell surface interactomes, we will globally probe for any autocrine binders in the sheddome
of cancer cells. Lastly, we will develop antibody-based selective protease inhibitors by Epitope-Directed-
Selections to determine the substrates of candidate dysregulated proteases (SA3). We want to address what
are the cell surface proteases that are doing the cleavage and what are their substrates? We will start by
employing recombinant antibodies we designed recently in our current R01 that prevent activation of matrix
metallo-proteases that are key enzymes in remodeling cell surface proteins for invasion and metastasis. In sum,
we believe our work will significantly impact the functional understanding of shedding events in cancer, and
identify new biomarkers and immunotherapeutic targets.

Public health relevance
Project Narrative Extracellular proteolysis is a hallmark of cancer and has major functional consequences for remodeling cell surface proteins including receptor activation and shedding of functional extracellular domains. Here, we will develop technologies to identify novel shed proteins of cell surface, deorphanize interacting partners of these shed proteins, and generate proteolysis inhibitors to interrogate specific proteolysis events on the cell surface of cancer cells. We believe our work will significantly impact the functional understanding of shedding events in cancer, and identify new biomarkers and immunotherapeutic targets.